Education and Training

N5. Education, Training, and Outreach Program Description and Aims. The overall goal of this Component is to create a seamless interface between the fields of cancer biology and the quantitative and/or physical sciences (e.g., mathematics, computational biology, engineering, physics) to promote integration of disciplines and contribute to the expansion of the Cancer Systems Biology field. The Education and Training Components will target undergraduate and graduate students, postdoctoral fellows, as well as faculty. The Outreach Component aims to target both the broader cancer biology and quantitative research communities. Aim 1. To educate a new generation of scientists on the application of mathematical and computational modeling to the study of cancer. We will implement focused activities including hands-on workshops, short meetings, and graduate courses. Aim 2. To train experimental biologists on the application of mathematical and computational modeling tools and those from the quantitative (physical) sciences on the current experimental systems used to populate models. Execution of this Aim will be centered on exchange programs and Summer schools. Aim 3: To expand our reach to the scientific community by sharing experimental data, analysis tools, and models developed within the Center. We will implement sharing data, models, and analysis tools developed in the Backbone of our Center with the scientific community at large.